Mentoring Multidisciplinary Global HIV Patient-Oriented Research

Project Summary
Joseph D. Tucker, an Associate Professor in the Division of Infectious Diseases at the University of North
Carolina at Chapel Hill (UNC), submits this application for a K24 Mid-Career Award. Dr. Tucker is a nationally
recognized thought leader on HIV testing and crowdsourcing. Crowdsourcing is the process of having a group
of non-experts and experts develop a solution, then implement the solution in the community. In this
application, he proposes to develop skills that will serve his future work in this significant area of research,
including behavioral economics, participatory interventions, and strategies for effective leadership.
Candidate: Dr. Tucker has been a highly productive HIV clinical researcher and has developed a substantial
HIV research program in China. He has 208 peer-reviewed publications, including several research studies
that have informed national and global policy. Dr. Tucker is PI on two NIAID R01 research grants and one D43
Global Infectious Diseases Training Grant. He is Chair of the Burroughs Wellcome Fund/American Society of
Tropical Medicine and Hygiene Postdoctoral Fellowship Committee. As Director of the UNC-South China STD
Research Training Center, Dr. Tucker has helped to build capacity for HIV and STD co-infection research and
training in China. He has served as primary mentor for many new clinician investigators who have
subsequently become successful independent HIV researchers.
Mentoring Plan/Environment: This application will leverage the extensive training resources at UNC Project-
China in Guangzhou, China and at UNC. In China, the UNC-South China STD Research Training Center and
the SESH research team at Southern Medical University provide unique opportunities for research training. As
founding Director of UNC Project-China, Dr. Tucker is well-positioned to mentor students, fellows, and junior
faculty in China. In Chapel Hill, the UNC Center for AIDS Research, the North Carolina Translational and
Clinical Science (NC TraCS), and several HIV training grants provide research training that Dr. Tucker has
helped junior investigators join. As requests for mentoring have increased, Dr. Tucker proposes to receive
formal and informal guidance to develop further as a mentor.
Research Plan: The established research infrastructure Dr. Tucker and his collaborators have built in China
provides a strong platform for mentored research. Five studies led by Dr. Tucker have demonstrated that
crowdsourcing approaches are effective in developing sexual health messages for young men who have sex
with men (YMSM). The proposed study will evaluate crowdsourcing approaches to enhance HIV prevention for
YMSM. This will increase our understanding of differentiated HIV prevention services and provide rich
opportunities for mentee research and training.

Public health relevance
Project Narrative HIV incidence remains high among young men who have sex with men (MSM) around the globe. Innovative strategies for HIV prevention are critical to a comprehensive HIV response, particularly in low- and middle- income countries. The proposed midcareer award provides protected time to support mentorship of new investigators undertaking patient-oriented HIV prevention research, building capacity for further HIV prevention research in global settings.